Cancer Models Development Shared Resource

PROJECT SUMMARY CANCER MODELS DEVELOPMENT RESOURCE
The Cancer Models Development Resource Shared Resource (CMDR) advises and supports JAX Cancer
Center (JAXCC) members in the design, development, and use of advanced mouse models for cancer research,
including genetically engineered mouse models (GEMMs), genetically diverse mapping panels, and patient-
derived xenograft (PDX) platforms. The construction and management of mouse models has become a complex
process requiring the expertise of specialized technical experts from different disciplines. While JAX is
institutionally recognized for its technical expertise in mouse model creation and interrogation, a limiting factor
for JAXCC members, particularly those not steeped in murine biology, remains access to expert technological
consultation and project management services. Thus, the primary goals of the CMDR are to support the use of
existing mouse cancer models for all interested JAXCC members and to facilitate the process for those with
limited experience or capacity for modeling cancer in mice in their own labs. The CMDR provides expertise in
GEMMs and PDX mouse modeling, mouse genetics, molecular biology, project management, colony
management, animal care, and regulatory compliance. According to the needs of a specific project, the CMDR
coordinates the activities of other CCSG-supported Shared Resources. The CMDR also serves as a bridge for
JAXCC investigators at the Farmington campus, enabling simplified access to the animal resources and
expertise available at the Bar Harbor campus. As a component of JAX's Genetic Resource Science group (GRS),
the CMDR has ready access to expertise in molecular, neurobiological, reproductive, and developmental biology
in addition to a long history of mouse resource development and skilled animal care and husbandry. To
accomplish our goal of being a one-stop resource for cancer model development and use, we propose two
Specific Aims: 1) Support the development and/or use of genetically engineered mouse models; and 2) Provide
consultation and project management support for the use of patient-derived xenograft mouse models.